Charting somatic evolution via single-cell multiomics

PROJECT SUMMARY
This proposal outlines a five-year career development program for Caleb Lareau, Ph.D. to prepare him
for an independent research career in human genomics to study cellular processes underlying complex
disease. The candidate will conduct his postdoctoral training at Stanford University, which provides an
outstanding environment to complete the proposed research and develop skills in massive-scale computational
analyses, genomics technology development, and immunology. Dr. Lareau’s mentors and advisors, including
Drs. Satpathy, Kundaje, Greenleaf, Howitt, Curtis, and Anderson, have diverse technical expertise relevant to
all aspects of the proposal and track records of guiding trainees to independence. Further, the candidate will
utilize world-class resources available through the Stanford School of Medicine, Office of Postdoctoral Affairs,
and NHGRI-funded Centers at Stanford to acquire career development skills while interfacing with leaders in
genomics. Additionally, the research infrastructure within his mentors’ labs will enable him to efficiently perform
the scientific aims, receive training in areas encompassed by this proposal, and transition to independence.
The goal of this work is to develop single-cell genomics methods to chart somatic evolution throughout
the human body. Evidence from recent bulk sequencing studies has indicated that somatic evolution occurs in
almost all tissues, but current approaches lack sensitivity to resolve clonal expansions, associated cell states,
or their prevalence throughout the body. A key bottleneck in studying somatic evolution has been limitations of
genomics technologies, which if addressed, may lead to insights into the pathogenesis of diseases like cancer.
In Aim 1 (K99), the candidate will establish a new single-cell approach for measuring accessible
chromatin, protein abundance, and mitochondrial DNA mutations to identify clonal expansions and related cell
state changes. In Aim 2 (K99), the candidate will apply multi-omics technologies to identify the origins and
expansions of macrophages within human gynecological tissues and tumors. After transitioning to a faculty
position for Aim 3 (R00), the candidate will focus his effort on creating massive-scale single-cell whole-genome
sequencing methods that are paired with functional measurements, including RNA or protein quantification. All
Aims will utilize and build upon cutting-edge single-cell multi-omics technologies to study somatic evolution.
Together, the pursuit of this research will result in tools and insights that will directly inform properties of
human tissue physiology and aid in the early detection, characterization, and understanding of age-associated
diseases, including cancer. All protocols, data, analytical frameworks, and software tools that are produced
during the duration of this research will be freely distributed. In total, the proposal will lead to novel insights into
the molecular signatures and regulation of somatic evolution and serve as an effective training program for Dr.
Lareau to launch his independent career as a tenure-track investigator.

Public health relevance
PROJECT NARRATIVE The composition of cells in tissues evolves over time as changes to DNA alter a cell’s ability to adapt, expand, or die— a process called somatic evolution. Here, the proposed research will develop new genomics approaches to study somatic evolution in human tissues at single-cell resolution. As somatic evolution plays an important role in the predisposition to many diseases, including cancer, the successful completion of this research will reveal basic biological insights that may enable earlier detection of disease and unlock new opportunities for therapeutic intervention.